Life Course Energy Balance and Breast Cancer Risk in Black/White Women Under 50

DESCRIPTION (provided by applicant): The etiology of breast cancer in younger women (diagnosed < 50 years of age) is poorly understood and understudied. These cancers have a higher prevalence of more aggressive, hormone receptor negative tumors and are associated with poorer prognosis. The incidence rate among women through age 40 years is higher among Black vs. White women, but risk appears to be increasing among White women in the United States. Young Black women also have a higher prevalence of more aggressive, hormone receptor negative tumors. Recent evidence suggests this may also be true for women of lower socioeconomic status (SES). Potentially modifiable risk factors related to energy balance over the life course (e.g. growth patterns, pubertal maturation, adiposity, insulin resistance, diet and physical activity) have been implicated in the etiology of breast cancer in younger women. The objectives of this study are to investigate, in a socioeconomically diverse population of Black and White women, whether life course (in utero/perinatal, childhood, adolescent, and adult) energy balance factors, or polymorphic variation in candidate genes in energy balance pathways, are associated with breast cancer risk overall and by tumor subtype. Specific Aims: Among Black and White women < 50 years, we propose: 1) To investigate the association between adult energy balance factors-general (subcutaneous) adiposity, central (visceral) adiposity, serum adipokine biomarkers, an insulin resistance related diet pattern, and physical activity-with breast cancer risk; (2) To examine the association between early life energy balance factors-growth, adiposity, and onset of menses-with breast cancer risk; and (3) To study joint associations between life course energy balance factors-aforementioned adult and early life factors-with breast cancer risk. All associations will be studied, (a) by race (Black/White) and SES, (b) jointly with candidate genes in the energy balance pathway (based on function and genome wide association studies), and (c) for overall breast cancer and by tumor subtype (basal-like, HER2+/estrogen receptor (ER)-, Luminal A, and Luminal B). Methods: We propose to conduct a population-based case control study of 2,000 incident in situ and invasive breast cancer cases, diagnosed from 2011 to 2014, in Black (n=1,000) and White (n=1,000) women aged < 50 years residing in Metropolitan Detroit and Los Angeles County SEER areas, and a population-based sample of 2,000 control women frequency-matched on age, race and SEER area. We will collect anthropometric measurements, blood, photographs, questionnaire data on life course energy balance and other known risk factors, and tumor tissue. Significance: Our proposed study will, (1) provide insight into potentially modifiable risk factors for breast cancer in younger women, (2) examine risk factors for specific breast tumor subtypes, including the aggressive basal-like/'triple negative' tumors, (3) be the largest study of breast cancer in younger African American women, (4) have the ability to investigate the joint effect of race and SES, and (5) create a bio-repository of blood, tumor tissue microarrays and DNA for current and future study.

Public health relevance
PUBLIC HEALTH RELEVANCE Breast cancer (BC) in younger women has a greater prevalence of tumors with poor prognosis and is most common in African American women under 40 years of age. Little research has been conducted on causes of BC in young women, particularly by molecular tumor subtypes, but energy balance factors over the life course (growth patterns, onset of menses, body size, physical activity, diet and related genes) have been implicated. This project - the largest study to date of BC in young African American women - will integrate information over the life course to investigate these risk factors overall and by molecular tumor subtypes to lay the foundation for further research, identify populations at highest risk and determine opportunities for modifiable intervention and prevention. Project Narrative Breast cancer (BC) in younger women has a greater prevalence of tumors with poor prognosis and is most common in African American women under 40 years of age. Little research has been conducted on causes of BC in young women, particularly by molecular tumor subtypes, but energy balance factors over the life course (growth patterns, onset of menses, body size, physical activity, diet and related genes) have been implicated. This project - the largest study to date of BC in young African American women - will integrate information over the life course to investigate these risk factors overall and by molecular tumor subtypes to lay the foundation for further research, identify populations at highest risk and determine opportunities for modifiable intervention and prevention. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Breast cancer in younger women (diagnosed < 50 years of age) has a greater prevalence of tumors with worse prognosis29-33. Incidence rates are higher among African American than White women through age 40 years34, but rates appear to be increasing among young White women34. African American women29 32 and possibly women of lower socioeconomic status (SES)22 35-42, also have a higher prevalence of poor prognosis tumors. Factors related to life course energy balance-including early life growth patterns, childhood adiposity, onset of menses, adult adiposity, insulin resistance, diet and physical activity-are linked with breast cancer risk, and risk may differ by molecular tumor subtypes. Yet, limited data exist on breast cancer by tumor subtypes, or life course energy balance factors in young women, and underlying biologic mechanisms are poorly understood. The identification of modifiable energy balance factors to inform breast cancer prevention efforts is critical. We propose to conduct a population-based case-control study of life course energy balance factors and breast cancer risk in Black and White women < 50 years of age who have diverse socioeconomic backgrounds. We also will investigate whether risk differs by molecular tumor subtypes, including for basal- like/triple negative tumors32, and by polymorphisms in genes on the energy balance pathway. Our proposed study combines resources of 2 National Cancer Institute (NCI) Surveillance, Epidemiology, and End Results (SEER) registries with large numbers of African American breast cancer patients-the Metropolitan Detroit and Los Angeles County registries. We propose to recruit 2,000 breast cancer cases diagnosed in 2010-2014 and 2,000 control subjects identified through a population-based sample design. Black and White women will be equally represented. Our transdisciplinary study has 4 primary components that integrate population-based epidemiology with molecular biology: (i) collection and analysis of questionnaire data and body size measurements pertaining to life course energy balance exposures; (ii) collection of tumor tissue, creation of tumor microarrays and immunohistochemical analysis of molecular tumor subtypes; (iii) collection of blood and analysis of serum biomarkers of adiposity and insulin resistance; and (iv) collection, analysis of polymorphisms in candidate genes in the energy balance pathway, and DNA storage for future collaborations. Aim 1: Adult Energy Balance and Breast Cancer Risk in Women < 50 Years. To determine the association between adult energy balance represented by: a) general (subcutaneous) adiposity, b) central (visceral) adiposity, c) insulin resistance related dietary patterns, and d) physical activity, and breast cancer risk in women <50 years of age overall and by race (Black/White) and SES. Hypotheses: A young woman's breast cancer risk will be: 1) decreased with general (subcutaneous) adiposity (through it's correlation with childhood adiposity and associated decreased breast density and menstrual cycle irregularities43); 2) increased with central/visceral adiposity (waist circumference) (though associated insulin resistance); 3) increased with intake of an insulin resistance related dietary pattern (through risk of insulin resistance); 4) decreased with physical activity (through it's affect on reducing insulin sensitivity); and 5) risk associated with these measures of energy balance will be similar by race (Black/White) and SES. Aim 2: Early Life Energy Balance and Breast Cancer Risk in Women < 50 Years. To investigate the association of early life energy balance represented by: a) in utero growth, b) childhood growth, c) childhood adiposity, d) age at menarche, and e) physical activity, with breast cancer risk in younger women (<50 years of age) by race (Black/White) and SES. Hypotheses: A young woman's breast cancer risk will be: 1) increased with higher infant in utero growth (birth weight-for-gestational age) (through increased proliferation of breast stem/progenitor cells susceptible to later mutation44); 2) increased with childhood growth (taller height and longer leg and trunk length) (through prolonged exposure to growth factor and insulin exposures during breast development); 3) decreased with childhood adiposity (body silhouettes at ages 5, 10, 15 and 18) (through increased early exposure to sex hormones from adipocytes that render breast tissue estrogen and/or insulin insensitive to later adult hormonal and growth factor exposures45); 4) decreased with early (<11 years) and late (> 14 years) age at menarche (through hormonal modulations); 5) decreased with physical activity (through its influence on insulin and sex hormones). Aim 3: Lifecourse Energy Balance and Breast Cancer Risk in Women < 50 Years of Age. To investigate joint effects of early life (in utero/perinatal, childhood and adolescent) and adult energy balance factors described in Aims 1 and 2 and breast cancer risk in women <50 years by race (Black/White) and SES. Sub-Aim: Life course energy balance and biomarkers of adiposity. Among controls, to evaluate correlations between anthropometric and self-reported life course measures of energy balance with biomarkers of subcutaneous and visceral adiposity/insulin resistance in women < 50 years of age overall and by race (Black/White) and SES. Hypothesis: Energy balance factors influence the growth factor and hormonal milieu, affecting the number of susceptible stem/progenitor cells in utero and during childhood and puberty-when critical proliferative and morphological changes occur in the breast. These changes modify breast tissue sensitivity to adult exposure to hormones and growth factors during reproductive years, influencing breast cancer risk in young women. Aim 4: Breast Molecular Tumor Subtypes and Life Course Energy Balance in Women < 50 Years. To investigate the association between lifecourse energy balance factors (in Aims 1-3 above) and breast molecular tumor subtypes in younger women <50 years of age, by race (Black/White) and SES. Sub-Aim: Biomarkers of Adiposity and Breast Molecular Tumor Subtypes. Among cases only, by stage at diagnosis and adjuvant treatment status, to explore whether biomarkers of subcutaneous and visceral adiposity/insulin resistance differ by molecular tumor subtypes. Tumor subtypes: 1. basal-like (estrogen receptor (ER)-, progesterone receptor (PR)-, HER2-, cytokeratin 5/6+); 2. HER2+, ER- subtype; 3. Luminal A (ER+ PR+, HER2-); or 4. Luminal B (ER+, PR+, HER2+)46. Hypotheses: 1) Childhood adiposity will be associated with a decreased risk of Luminal A or B (ER+) tumors ( the majority (~65%) of premenopausal tumors), and, thus, to an overall decrease in breast cancer risk (through adiposity's desensitization of ER+ cells to estrogen later in life). 2) Childhood adiposity will be associated with an increased risk for basal-like tumors with cells that resemble ER- stem/progenitor cells (through associated increased production of insulin and growth factors). 3) Increased adult waist circumference, increased intake of an insulin resistance related dietary pattern, and low physical activity, will be associated with increased risk for basal-like tumors in young women (again, through increased production of associated insulin and growth factors). Aim 5: Genes Related to Energy Balance and Breast Cancer Risk in Women < 50 Years. To investigate (a) the contribution of common genetic variants in candidate genes related to energy balance to young women's breast cancer risk and, where possible, to explore (b) interactions between these common genetic variants and energy balance related factors overall, by race (Black/White), and by SES. Candidate genes will be selected for association with: (i) breast cancer, (ii) general (subcutaneous) adiposity, (iii) central (visceral) adiposity, insulin resistance, or type II diabetes, and (iv) growth (age at menarche and height). Working hypothesis: Genes related to energy balance will be associated with breast cancer risk and will modify the influence of energy balance-related environmental factors on breast cancer risk. Figure 1. Life Course Energy Balance and Breast Cancer Risk in Black & White Women < 50 Years